STRUCTURE AND INTERACTIONS OF BIOLOGICALLY IMPORTANT MACROMOLECULES

Cooperative binding systems are being studied taking into account site or subunit interactions, ligand interactions, aggregation and redistribution in proteins, and model systems. Methods are being developed to evaluate reasonable values for the parameters describing these systems, particularly those involving the action of fibrinogen and the processes of protein-DNA interactions.